EFFICACY OF DRUG HOLIDAY FOR TREATMENT OF PARKINSON'S DISEASE

To investigate the tolerability, safety, and efficacy of "drug holiday" (withdrawal of antiparkinsonian medication) for the treatment of Parkinson's disease. Specifically we will investigate: 1. The acute effects of antiparkinsonian medication withdrawal on autonomic function. 2. The acute effects of a 4 day drug holiday on the responsiveness of the post synaptic dopamine receptor. 3. The chronic effects of a 4 day drug holiday on medication requirements, medication response, drug-induced hallucinations, sleep quality and quality of life in patients with complicated Parkinson's disease. 4. The safety of a 4 day drug holiday in patients with complicated Parkinson's disease.